Discovery of structural RNAs involved in human health and disease

Many fundamental cellular functions depend on a variety of RNA structures conserved through evolution, and
other functional RNA structures are expected to be discovered. A signature of a conserved RNA structure is
found in alignments where paired positions display correlated substitutions (covariation) that preserve the base
pair. This evolutionary signal can be used both to predict RNA structure and to identify new conserved RNAs.
Recent publications and preliminary results have made three important advances: A statistical covariation
test that identiﬁes signiﬁcant covariation over background covariation due to phylogeny. This test, implemented
in a method called R-scape (RNA Structural Covariation Above Phylogenetic Expectation), provides information
and control over the rate of false positive predictions. A power of covariation calculation, recently published,
that identiﬁes “negative” pairs with power (variation) but insigniﬁcant covariation, unlikely to form RNA base pairs.
A new cascading folding algorithm, named CaCoFold (Cascade covariation/variation Constrained Folding)
also recently published, that combines all positive and negative evolutionary information into complex structures
including all types of pseudoknots and triplets. In human, the efﬁcacy of these advances has been tested by ac-
curately predicting the structures of the human non-coding RNAs MALAT1 and telomerase RNA, and by inferring
that the non-coding RNAs HOTAIR and XIST do not have a conserved structure.
These three advances give us a competitive advantage to perform unbiased genome-wide screens for con-
served structural RNAs in vertebrates with accurate 3D structure prediction. Previous vertebrate screens
for structural RNAs have been hindered by thousand of false positive predictions. In contrast, our new covariation
statistical test allows for controlling the rate of false positives. R-scape has already been used to ﬁnd struc-
tural RNAs in bacteria and viruses. Our recent eukaryotic pilot screen in fungi has identiﬁed 17 novel structural
RNAs. We hypothesize that many structural RNAs with implications for human health and disease are still to be
discovered, and that we now have the tools to ﬁnd and characterize these RNAs.
This proposal has three speciﬁc aims that will advance the study of structural RNA biology, and the discov-
ery of novel biological mechanisms involving RNA structures. The ﬁrst aim proposes systematic genome-wide
searches to ﬁnd novel conserved vertebrate RNA structures in human. The second aim proposes to combine
revolutionary 3D structure prediction methods in machine learning with the signals used by CaCoFold into a
state of the art RNA folding method for the accurate prediction of 3D RNA structures. The third aim introduces a
method to identify RNA structures in ultra conserved vertebrate UTRs where there is no covariation signal,
and our current method lacks power. We expect our work will unveil primate-speciﬁc novel regulatory mecha-
nisms. Novel human RNA structures found to have causal variants associated with disease will be prioritized for
experimental veriﬁcation.

Public health relevance
Project Narrative Many biologically important sequences of ribonucleic acid (RNAs) fold into speciﬁc 3D structures conserved through evolution, but knowing when an RNA sequence includes a conserved RNA structure is not trivial and depends on clues left behind by conservation: covariation and variation. We have developed state of the art methods based on evolutionary conservation to identify when a conserved RNA sequence includes a conserved structure (R-scape), and to predict the RNA structure of those that have one (CaCoFold); these methods are more accurate and have fewer false predictions than other previous methods, which makes them suitable for the detection and analysis of conserved RNA structures in complex eukaryotic genomes. We propose three lines of research: to systematically identify novel structural RNAs in vertebrates with special emphasis on the experi- mental characterization of those involved in human health and disease; to produce novel methods to accurately determine their 3D structure; and to produce next generation methods exploiting pre-covariation signals to detect novel primate-speciﬁc structural RNAs relevant to human health.